Development of an early detection test for Type 1 Diabetes via NGS-based analysis of β cells-specific methylation patterns in cfDNA

PROJECT SUMMARY
Type 1 diabetes mellitus (T1D) is a chronic autoimmune disease that affects ~1.5M Americans, characterized by
persistent hyperglycemia requiring life-long administration of external insulin. T1D is caused by the immune
system-derived death of the insulin-producing β cells in pancreatic islets. Because insulin production is initially
sustained by a higher output from surviving β cells, overt symptoms arise when 80%+ of β cells have been lost,
making diagnosis only possible at a stage of advanced disease. Islet autoantibodies, the only established T1D
biomarkers, are valuable for assessing long-term disease risk. However, because they cannot inform on the rate
of β cell death, autoantibodies cannot precisely predict when the disease will strike. Therefore, a technology
capable of identifying β cell death during the asymptomatic stages of T1D would provide an invaluable diagnostic
tool for the early detection of T1D, allowing earlier intervention with immunosuppressive therapies and delaying
critical islet mass loss.
To address this gap, Pupil Bio is developing an approach leveraging next-generation sequencing for
methylation analysis (methyl-seq) of cell-free DNA (cfDNA). Each cell and tissue type carries unique methylation
patterns, which can inform on the cellular origin of DNA molecules in a mixed sample such as cfDNA. cfDNA is
released by dying cells as a result of cellular turnover or of an active injury occurring to a tissue. Thus, detecting
methylation patterns specific to cell types that are not usually found in healthy cfDNA can reveal ongoing damage
to a tissue during a pathogenic process, allowing for non-invasive, specific early detection. Available technologies
for methyl seq-based early detection fail to achieve high sensitivity, and require high volumes of blood. We
propose that high cumulative sensitivity can be obtained by (i) combining a high number of methylation markers
with non-zero sensitivity, and (ii) implementing an amplicon-based NGS workflow that minimizes sample loss.
In this Fast-track SBIR application, the Pupil Bio team proposes to first apply a custom hybrid capture
panel to validate thousands of candidate methylation patterns that are ultra-specific to pancreatic islets. In
parallel, we will build and characterize an initial amplicon-based panel implementing a novel algorithm for highly
multiplexed primer design in methyl-seq. Next, we will hone the list of candidate markers by identifying patterns
that are ultra-specific to β cells only via high-depth sequencing, and expand the amplicon-based panel to
hundreds of amplicons. Finally, after analytical validation, we will characterize the clinical sensitivity of the panels
by testing samples from recent-diagnosis T1D patients, and demonstrate we can achieve high sensitivity while
requiring small blood amounts. Completion of these studies will allow Pupil Bio to establish a CLIA lab and to
commercialize its test as a laboratory-developed test (LDT) for the early detection of T1D.

Public health relevance
PROJECT NARRATIVE There are currently no biomarkers for the early, highly specific detection of β cell death during the pathogenesis of Type 1 Diabetes (T1D). Islet autoantibodies, the only available T1D biomarkers, can only predict disease risk with limited specificity, and cannot inform on the rate of β cell loss. The goal of this proposal is to build a diagnostic test for the early detection of T1D with high specificity and sensitivity, via the NGS-based identification of hundreds (up to 1,000) of methylation markers in cell-free DNA (cfDNA) that are ultra-specific to β cells.